Administrative Core

Project Summary.
The Administrative Core supports the four Resource Cores of the Vision Center Core at Washington
University. The Four Resource Cores are: Imaging, Molecular Genetics, Visual Function Testing, and
Biostatistics & Bioinformatics.
The Administrative Core supports the overall management of the Center Core by providing an organizational
structure by which the efforts of the four Resource Cores are coordinated. With the help of the Internal
Advisory Group (the steering committee for the Center Core), the Administrative Core controls the distribution
and utilization of funds, provides a mechanism for dispute resolution, furnishes the NEI with timely updates (in
the form of RPPR reports) as to the progress of the Center Core, and helps implement changes in services or
staffing to keep the Core finely attuned to the scientific needs of the user group.